Project-004

The pathophysiology of schizophrenia has been unknown, resulting in a lack of innovative
therapeutics with novel mechanisms of action. The Conte Center for Neuroimmune Studies was
created to build on our discovery that the biology underlying the most significant schizophrenia
common genetic risk variants involves neuroimmune mechanisms of synaptic pruning. We have
found that risk variants of the complement component C4 genes are correlated with increased
C4A expression in the brain and CSF, and that overexpression of human C4A in a mouse model
results in excess synaptic pruning and social behavioral deficits. We have further shown that
additional neuroimmune molecules encoded at schizophrenia risk loci, CD47 and CSMD1,
influence synaptic pruning and complement activity. Lastly, schizophrenia is unusual among
neurodevelopmental disorders in its late-adolescent/early-adult onset, and childhood adversity is
a major non-genetic risk factor for schizophrenia; yet the biological underpinnings of adolescent
psychiatric vulnerability are wholly unknown. We have identified a critical period of circuit
refinement in the mouse frontal cortex that we propose can be exploited to better understand the
unique vulnerability of adolescent brain development to psychiatric risk factors.
The goals of the Center in our next five years are to both deepen the focus on C4-mediated
synaptic pruning as a pathophysiological mechanism, and expand the scope of our investigations
to create a fuller picture of neuroimmune pathways, their upstream regulators, their cellular
effectors, and their downstream circuit-level and behavioral impacts. Project 1 will investigate the
role of astrocytes, the main source of C4 in the brain, by manipulating schizophrenia risk genes
in these cells and assaying the impacts on synapse formation and function. Project 2 will spatially
map the brain’s transcriptional response to C4 overexpression, and test the therapeutic
hypothesis that inhibition of C4 activity may rescue over-pruning and associated behavioral
phenotypes. Project 3 will examine the circuit specificity of the adolescent critical period, the
impacts of gene-by-environment risk factor interactions, and the roles of the brain borders. Project
4 will explore circuit-level interactions between the basal ganglia and frontal cortex in the context
of adolescent development, psychiatric risk factors, and risk/reward decision-making. We will also
lay the groundwork for expanding neuroimmune studies of psychiatric risk to a non-human
primate model, the marmoset. Finally, our Administrative Core will facilitate interdisciplinary
collaboration that exploits the full range of expertise across the four labs, and coordinate outward-
facing activities including the annual research symposium.

Public health relevance
Overall Narrative Our Center will work to reveal how genes and environment interact with neuroimmune cells and signaling to shape aspects of brain development that may go awry in neuropsychiatric illness. We will do this by deploying scientific approaches from neuroscience, immunology, and genomics, spanning levels from molecules to behavior and leveraging both mouse and marmoset model species, as well as human tissues and cellular models.